A large scale investigation of the vaginal ecosystem in preeclampsia

ABSTRACT
Preeclampsia is a pregnancy complication characterized by high blood pressure and signs of systemic organ
damage, often the liver and kidneys. It poses significant clinical challenges in terms of accurate early prediction
and effective prevention and treatment, with grievous maternal and neonatal consequences. One promising yet
relatively unexplored avenue is the vaginal ecosystem: its microbiome, metabolome, and host immune
components. The vaginal microbiome is capable of influencing systemic and local inflammation, producing a
wide range of metabolites, and is the likely source for ascending infections with the ability to translocate to
other reproductive organs. It may therefore provide insights that will advance our understanding and
management of preeclampsia. This project therefore proposes an in-depth study of the vaginal ecosystem in
severe preeclampsia, aiming to uncover the microbial and molecular properties of the vaginal ecosystem that
indicate, predispose to, or contribute to preeclampsia. We hypothesize that the early pregnancy vaginal
microbiome is strongly associated with subsequent development of preeclampsia, facilitated by specific
microbes, host immune states, or microbial metabolites. We will capitalize on one of the largest and most well-
phenotyped pregnancy cohorts collected to date, the nuMoM2b study. This was a diverse, national, multi-
center cohort that collected detailed clinical data in addition to vaginal swabs at three time points along
pregnancy. We will conduct longitudinal metagenomic and metabolomic profiling of ~4,200 vaginal samples
from 389 nulliparous pregnancies with severe preeclampsia and 389 matched controls, in addition to profiling
host immune factors using immunoassays. This dataset would contribute significantly to the microbiome
community, drive discovery in the field, and enable us and other researchers to study host-microbiome
interactions, in general and specifically in the context of preeclampsia, with an unprecedented depth. Using this
data, we will identify microbial associations with severe preeclampsia, longitudinally and cross-sectionally, and
their interactions with host immune factors. We will further use a metabolomics approach focused on broad
structural annotation and identifying metabolite sources to detect vaginal metabolites associated with
preeclampsia, aiming to elucidate their roles as mediators of host-microbiome interactions. We will combine all
collected molecular data along with clinical covariates to devise supervised machine learning models that
predict the risk for preeclampsia early in pregnancy. Findings from this project would illuminate the potential
processes by which the vaginal microbiome influences preeclampsia, providing specific mechanistic
hypotheses for future validation and possibly leading to new therapeutic targets and diagnostics.

Public health relevance
NARRATIVE Preeclampsia is a serious pregnancy complication with limited diagnostic and treatment options. Our project aims to investigate the role of the vaginal ecosystem - its microbes, metabolites, and the host’s immune system - in preeclampsia, using samples from a large and deeply phenotyped cohort of pregnant women - the nuMoM2b study. Our study will identify new biomarkers for preeclampsia and highlight potential mechanisms underlying it, ultimately paving the way for new diagnostics and therapeutic targets that will improve maternal and neonatal health outcomes.